Mechanisms of Synaptic Specificity in Visual Circuits

ABSTRACT
Efficient sensory processing requires the development of precisely wired circuits. Sensory deficits are common
in neurodevelopmental disorders (NDDs), such as fragile X syndrome (FXS), underscoring the importance of
proper wiring. Despite this, the mechanisms underlying precise sensory circuit wiring and the etiology of sensory
dysfunction in NDDs remain poorly understood, precluding development of effective therapies. To address these
gaps in knowledge, we have utilized the visual circuitry of the mouse superior colliculus (SC) to elucidate
fundamental mechanisms of circuit wiring and uncovered novel sub-circuit-specific visual deficits in FXS mice
(Fmr1-/y). In the parent proposal to this supplement, we focus on the mechanisms by which topographic maps of
space encoded by retinal ganglion cells (RGCs) in the eye and Layer 5 neurons in primary visual cortex (L5V1)
are brought into alignment in the SC. Previous studies by us and others suggest that each stage of visual circuit
development in the SC - RGC mapping, visual map alignment, and circuit consolidation - is dependent on
neuronal activity; however, the mechanisms underlying each are poorly understood. Based on our previous and
preliminary data, we propose a model in which the activity-dependent mechanisms underlying each stage of
visual circuit development in the SC are distinct. We will test this model in three specific aims, leveraging a
unique combination of cutting-edge techniques and novel genetic mouse models. In this supplement, we will
focus on Aim 2 of the parent grant in which we will explore the region- and stage-specific roles of Fmr1, leveraging
anatomical tracing and in vivo electrophysiological methods. In addition, we will expand the scope of this aim to
determine the region- and stage-specific roles of Fmr1 in establishment of circuits regulating an innate behavior
regulated by the SC, namely prey capture. These studies will not only advance our understanding of circuit
assembly in the visual system and provide novel insights to sensory dysfunction in FXS, but also provide a rich
training opportunity for the candidate. Indeed, the candidate will learn several novel techniques to add to his
experimental toolbox, develop skills in data analysis, data presentation, and scientific communication, and build
professional skills and networks to help him launch a successful career in health-related research.

Public health relevance
NARRATIVE Unchanged from parent grant.